HIV/AIDs and Orphan Care

DESCRIPTION (provided by applicant): Worldwide, 143 million children are estimated to have lost one or both parents, 15 million to HIV/AIDS alone. Millions more children have been abandoned and are in need of care. The need to understand individual, family, community, and structural factors influencing positive outcomes for orphaned and abandoned children (OAC) across and within different cultures is pressing. The goal of this competing renewal application is to continue to follow an existing cohort of more than 3,000 randomly selected OAC in six culturally diverse study sites in Cambodia, Ethiopia, India (Nagaland and Hyderabad), Kenya, and Tanzania. Children enrolled in the Positive Outcomes for Orphans (POFO) cohort were aged 6-12 at baseline; half were enrolled from family settings, half from 83 institutional care settings. Children were followed for 2-3 years with a retention rate of >87%. POFO children will be aged 10-16 at the close of the study in May 2010 and are transitioning to adolescence and young adulthood, perfectly positioning the cohort to help us understand predictors of positive outcomes such as retention in school, employment opportunities, and civic engagement, and predictors of negative outcomes such as high risk sexual and drug use behaviors, early pregnancy, and engagement in sex trade. Many of the OAC in this cohort were orphaned or abandoned due to HIV/AIDS, the consequences of which may now place them at risk for engaging in behaviors that make them more likely to become HIV infected and/or spread the disease. We propose to follow this cohort for 4 years and examine the influence of intrapersonal, interpersonal, and community level factors on: 3 behavioral and relationship outcomes: HIV risk behaviors, reproductive health, and family formation, and 3 achievement outcomes: continued education, income generating activities (IGAs) and civic engagement. The cohort will be followed through ages 14-20 during the proposed study period. Building on the success of POFO I, which has received international attention, this application has the highest level of support from Duke University and organizations in each of the countries with which we have been working, and a study-specific Advisory Board has been formed to help guide POFO I analyses and POFO II design and implementation. A minimum of 7 peer-reviewed manuscripts, a major policy document, and a book will result from this study. These documents will advise policymakers, programmers, and researchers on the caregiving and cultural characteristics that need consideration when planning for the transition of millions of orphaned children from childhood into young adulthood.

Public health relevance
PUBLIC HEALTH RELEVANCE: The need to understand intrapersonal, interpersonal, and community level factors influencing positive outcomes for orphaned and abandoned children (OAC) across and within different cultures is pressing. This competing continuation for the Positive Outcomes for Orphans (POFO) study will identify such factors by continuing to follow more than 3,000 OAC as they transition to adolescence and young adulthood. The study is conducted over four years in six culturally diverse study sites in Cambodia, Ethiopia, India (Nagaland and Hyderabad), Kenya, and Tanzania. The need to understand intrapersonal, interpersonal, and community level factors influencing positive outcomes for orphaned and abandoned children (OAC) across and within different cultures is pressing. This competing continuation for the Positive Outcomes for Orphans (POFO) study will identify such factors by continuing to follow more than 3,000 OAC as they transition to adolescence and young adulthood. The study is conducted over four years in six culturally diverse study sites in Cambodia, Ethiopia, India (Nagaland and Hyderabad), Kenya, and Tanzania. __SpecificAimsTextDelimiter__ Specific Aims One hundred and forty-three million children are estimated to have lost one or both parents, 15 million of these to AIDS.1 Millions more have been abandoned by their parents. While Africa is most often referenced when discussing the orphan burden, South and Southeast Asian countries are caring for 67.5 million orphans.1 In both Africa and Asia, high mortality among young parents from conditions such as malaria, tuberculosis, HIV/AIDS, pregnancy complications, injuries, and natural disasters are responsible for the large and increasing number of orphans.2 Most children in less wealthy nations are orphaned not at birth but at older ages;1,3-4 36% of all orphans and 29% of double orphans are aged 6-11; almost half of single orphans and nearly two- thirds of double orphans are aged 12-17.5 Because of this, the study of older orphaned and abandoned children (OAC) is vitally important: knowledge is needed regarding the caregiving characteristics that result in positive outcomes for adolescents and young adults who are orphaned or abandoned, as is an understanding of how to reduce the risk of HIV transmission to and from this potentially high risk population. Policy makers recognize the importance of addressing the needs of orphans: through PEPFAR, the US alone has committed $43 billion over 5 years to services for orphans.6 However, the knowledge base of locally feasible and culturally appropriate ways to support positive outcomes for OAC is astonishingly small. The few studies that have been conducted tend to be of a single country and cross sectional, and do not have randomly selected care settings or samples. Additional evidence is required to identify positive and negative caregiving characteristics that transcend structure and culture in order to identify how to provide locally feasible and acceptable care for the millions of OAC in need. Positive Outcomes for Orphans (POFO I) followed more than 3,000 randomly selected OAC, half from family and half from institutional care settings, living in 6 culturally, politically, historically and religiously distinct sites representing nearly 100 ethnicities in 5 less wealthy nations. OAC aged 6 to 12 at enrollment were followed for 2-3 years, with a retention rate of >87%. POFO I aims were to understand predictors of physical and emotional wellbeing and cognitive development. POFO I received international attention as the first multi- country observational study to follow a large cohort of post-toddler OAC, examining the caregiving structures and characteristics that predict positive and negative outcomes. POFO I demonstrated that there were few differences, on average, between institution- and family-dwelling OAC across various dimensions of physical health, cognition, and emotional difficulties, but substantial variation within groups, indicating that caregiving characteristics and children's life circumstances, rather than residential structure, determine OAC wellbeing. 7 Other findings in manuscripts to date include that caregivers' health and wellbeing are the strongest predictors of OAC's health and engagement in excessive labor;8-9 and that for most of the OAC, the loss of a parent was only one in a series of potentially traumatic events, and that as the number of events increased, so did their emotional difficulties.10 The unique importance of the study has been recognized through invitations to present findings to an OVC expert think-tank meeting hosted by USAID/NIH,11 a UNICEF/UNAIDS/UN OVC policy recommendations meeting,12 and personal meetings with leaders at UNICEF to discuss policy implications of POFO I findings that were highly publicized in national and international media (Appendix A). UNICEF's Child Protection Section formed an ongoing working group to advise POFO I analyses, and some of the most influential OAC researchers have agreed to participate on the POFO Advisory Board and/or to advise and support the research in other ways (Appendix B, "POFO Advisory Board", and Letters of Support) As we continue to meet the aims of POFO I (16 additional manuscripts are underway or outlined), the participating children are transitioning to adolescence and young adulthood, perfectly positioning this cohort to help us understand predictors of positive outcomes as well as predictors of negative outcomes such as behaviors that will put them at high risk for HIV. High rates of exposure to multiple traumatic events and the absence of familial care and protection may make OAC more likely than others to engage in HIV risk taking behaviors and other adverse outcomes. To examine these essential questions, we request a 5-year continuation to follow the POFO I cohort to ages 14 to 20. By identifying predictors of these outcomes, critical knowledge will be gained to help inform local and global policies and programs that promote positive and mitigate negative outcomes. Aim 1: Identify predictors of 3 interpersonal relationship outcomes: HIV risk behaviors, reproductive health, and family formation. Intrapersonal, interpersonal and community level factors are hypothesized to be associated with OAC's HIV risk behaviors (including sexual risk and drug use/abuse), reproductive health (including pregnancy, pregnancy-related morbidity, and HSV-2), and family formation (marriage/partnership). Aim 2: Identify predictors of 3 achievement outcomes: continued education, income generating activities (IGAs) and civic engagement. Intrapersonal, interpersonal and community level factors are hypothesized to be associated with OAC's continued education (highest grade completed), income generating activities (earnings) and civic engagement.